Advancing Alzheimer's family caregiving interventions and research capacity in Vietnam

ABSTRACT Developing family dementia caregiver interventions that are both effective and scalable is important in the US and globally. We are requesting an administrative supplement (PA-20-272) to our current NIA parent grant “Advancing Alzheimer’s Family Caregiving Interventions and Research Capacity in Vietnam” (RO1AG064688; MPIs: Hinton and Nguyen). The administrative supplement is in direct response to the challenges of delivering the in-person intervention during the COVID-19 pandemic as well as difficulties engaging family caregivers in more remote rural areas. The supplement will augment the parent study by developing and testing a technology- enhanced (telephone, videoconferencing, text messaging) version of our intervention for Distant delivery using participants, recruitment methods, and procedures that mirror the parent clinical trial. Building on a robust and effective collaborative relationship between investigators in HIC (US and Australia) and the Vietnam National Geriatric Hospital (NGH), the parent R01’s overall goal is to test the efficacy of Resources for Enhancing Alzheimer’s Caregiver Health in Vietnam (REACH VN), a culturally adapted version of the REACH VA intervention. We request an administrative supplement to adapt REACH VN for technology-enhanced remote delivery (i.e., via telephone, videoconferencing, text messaging) to expand the accessibility and reach of our intervention. Because the research in Vietnam may have relevance to Vietnamese and other Asian American populations in the US, we also propose convening members of the research team and experts in ADRD caregiving research from the US to facilitate knowledge transfer. The activities supported by this supplement represent a unique opportunity to augment and complement the aims of the parent study and advance the science of family caregiver interventions to reach rural and other underserved and vulnerable populations in the US and low and middle-income countries.

Public health relevance
PROJECT NARRATIVE Worldwide, a large majority of persons with Alzheimer’s disease and related dementias (ADRD) reside Vietnam and other low and middle-income countries (LMIC) compared with high income countries, a trend that will be magnified in decades to come. ADRD are among the most disabling and costly neurodegenerative brain diseases and is a growing public health concern in Vietnam, one of the most rapidly aging countries in Asia. To address the public health challenge of ADRD in Vietnam, the goals of this supplement application are to develop and test a version of REACH VN, a culturally tailored multicomponent intervention for family caregivers, that can be delivered remotely (i.e., through phone, videoconferencing, text messaging). The project will be conducted through a partnership of investigators in Vietnam and in the US at the University of California, Davis.